Administrative Core

PROJECT SUMMARY/ABSTRACT
Administrative Core
The Administrative Core will continue to be responsible for the coordination and overall direction of the Cystic
Fibrosis Research and Translational Core Center (CFRTC). It is responsible for all fiscal management of the
biomedical core facilities, pilot and feasibility projects and the enrichment program. The core fosters interaction
and cooperation among core directors. Core personnel are responsible for organizing all seminars, outside
speakers, and the annual retreat, as well as the meetings of the External and Internal Advisory Boards. A
website for the Center is maintained by the core. In addition, the Administrative Core manages a shared
resource database that can be used by each of the core directors to facilitate tracking of projects and PIs that
utilize core services, as well as publications that result from projects supported by the core. The core staff
serves as the communication link between Seattle Children’s Research Institute (SCRI), the University of
Washington, and the NIDDK. The core will implement the Evaluation Plan tracking all metrics of success in the
coming grant cycle.